Scalable Computational Methods for Genealogical Inference: from species level to single cells

PROJECT SUMMARY
Massive amounts of genomic data are currently being generated, providing unprecedented opportunities for
biomedical researchers to characterize various biological components and processes. In order to utilize these
data to make new biological discoveries and improve human health, accurate models and scalable computational
tools need to be developed to facilitate analysis and interpretation. The central objective of this project is to
address this challenge by developing more realistic probabilistic models, scalable algorithms, and user-friendly
software tools to enable the biomedical research community to better harness large genomic data. Many prob-
lems in genomics rely on computational methods for inferring genealogical information from large sequence data
and interpreting the reconstructed trees. In this application, we propose to make significant strides towards im-
proving this line of research by developing a suite of robust and scalable algorithms for probabilistic models of
molecular evolution and genealogical inference across multiple timescales. We will achieve our goal by carrying
out the following specific aims: 1) A fundamental problem in statistical analysis of molecular evolution is esti-
mating model parameters, for which maximum likelihood estimation (MLE) is typically employed. Unfortunately,
MLE is a computationally expensive task, in some cases prohibitively so. In Aim 1, we will utilize a novel MLE
framework and modern optimization methods to develop a broadly applicable computational method that
achieves several orders of magnitude speedup in MLE while maintaining high statistical efficiency for
general models of molecular evolution. We will apply our tools to improve phylogenetic inference for two clin-
ically important superfamilies of membrane proteins in humans, namely G protein-coupled receptors (GPCRs)
and Solute carrier (SLC) transporters. 2) Because of meiotic recombination, the genetic variability within humans
cannot be represented by a single tree. Instead, there are millions of different trees across the genome, where
each position in the genome will tend to have its own tree that only differs minimally from the trees in nearby
sites. The collection of all these trees, and the set of recombination points creating new trees, is represented
by the Ancestral Recombination Graph (ARG), which has a number of applications in human genetics. Despite
substantial recent progress on reconstructing ARGs, however, current methods are either too slow to scale up to
large data sets, or they do not sample ARGs accurately from a well-calibrated posterior distribution. In Aim 2,
will develop a new scalable computational method to improve ARG reconstruction and sampling. We
will test the method extensively on simulated data, develop a number of applications, and apply it on a number
of different human data sets to illustrate its utility. 3) Applications of genealogical inference methods have been
rapidly growing in single-cell genomics. In particular, advances in CRISPR/Cas9 genome editing technologies
have enabled lineage tracing for thousands of cells in vivo, and the problem of reconstructing trees from such data
has received considerable attention recently. In Aim 3, we will develop scalable algorithms to reconstruct
time-resolved single-cell trees for thousands of cells sampled at multiple time points. We will also develop
a novel statistical method grounded in rigorous theory to improve fitness estimation from trees. We will apply the
methods developed here to analyze single-cell lineage-tracing data from an iterative metastasis experiment to
study cancer evolution, as well as B cell affinity maturation data from a highly innovative experimental design to
study germinal center evolution.

Public health relevance
PROJECT NARRATIVE This project will develop scalable computational methods for estimating probabilistic model parameters and in- ferring genealogical information across different timescales, which will significantly facilitate the analysis and interpretation of human genome variation as well as single-cell genomics data. The user-friendly software tools stemming from this research will be broadly applicable to scale up inference under many settings, thereby en- abling the biomedical research community to better harness massive genomic data to improve human health. In particular, the methods developed in this project will be applied to study the biology of metastasis in cancer and antibody maturation in the immune system.